Increasing Minority Physician and APRN Clinician-scientist Research Training To Equalize Addiction Medicine (IMPACT TEAM)

PROJECT SUMMARY (30 lines):
Advanced practice registered nurses and medical students, particularly those from groups underrepresented in
the biomedical and behavioral sciences, need (1) robust education and research training in substance use
disorders (SUDs) and (2) targeted encouragement and advanced training to promote careers in addiction
research. Therefore, this R25 science education program, Increasing Minority Physician and APRN Clinician-
scientist Research Training To Equalize Addiction Medicine (IMPACT TEAM), builds upon prior NIH initiatives
to promote clinician-scientist research career development. We propose that to increase the pipeline of the
available workforce of underrepresented nursing and medical practitioners who have research-based training
in SUDs to contribute to the size and diversity of the research workforce to ultimately advance the science on
the causes and consequences of substance use, we need to target outreach and engagement from these
student populations early in their careers to reduce attrition from research careers. The following specific aims
will enable us to attain this goal: (1) Develop and implement a rigorous outreach program recruiting members
of underrepresented groups using multiple strategies and existing Michigan State University initiatives to
engage these students; (2) Refine and deliver and interprofessional addiction curriculum for students; (3)
actively recruit a subset of students engaged in training under Aim 2 to participate in interprofessional research
collaborations geared toward launching a research career. To accomplish this, we will promote engagement
through outreach programming aimed at underrepresented and disadvantaged students. We will provide the
students with interprofessional curricular exposure to principles of addiction medicine practice and research.
Lastly, we will leverage existing university resources and collaboratives to create a robust mentor group
consisting of accomplished NIH-funded researchers from many backgrounds to support students through
early-preprofessional research. Our mentors will assist students in exploring SUD research through a
publication/presentation disseminating SUD research. Through this program, we will assist students'
exploration of research through mentored research projects to engage them early in their education. This effort
will promote a pipeline of advanced practice registered nurses and physician clinician-scientists from
underrepresented and disadvantaged backgrounds poised to be future leaders in providing SUD healthcare
and conducting research to implement and disseminate evidence-based SUD care.

Public health relevance
PROJECT NARRATIVE (Population Health Statement) (3 sentences) This application proposes to create a pipeline of underrepresented and disadvantaged addiction researchers to increase the available workforce of practitioners who have research-based training in substance use disorders to bring a broader diversity to the clinician-science workforce. This program will provide education on the clinical, social, and basic sciences underlying substance use disorders and support student research with NIH-funded researchers. The program's goal is to develop a "pipeline" of underrepresented and disadvantaged doctorate prepared nurses and physicians equipped to work in multidisciplinary research teams to provide evidence-based care for substance use disorders and hasten the translation and development of substance use disorder research.